Data Science Foundations: Tools and Statistics for Modern Biomedical Research in the Cloud

Abstract
Data exploration, analysis, and visualization are integral to modern pharmacological research. We propose a
cloud-based learning module focused on best practices in these areas, with an emphasis on creating repro-
ducible workflows and understanding statistical principles relevant to large datasets. This module will support
research training under the parent T32 ‘Pharmacological Sciences Training Grant’ by enabling trainees to effec-
tively employ cloud computing and establish reproducible data analysis workflows with JupyterLab Notebooks
and GitHub. It will also facilitate the application of contemporary software tools for data analysis and visualiza-
tion, and provide a solid understanding of the key statistical principles involved. In summary, this module will
offer a comprehensive educational experience in data science and statistical principals, tailored specifically for
large genomic datasets. Its reach extends beyond our T32 trainees, including biomedical graduate students from
various disciplines. Additionally, it caters to an indeterminate number of online learners, broadening its impact
and accessibility in the field of pharmacological research.

Public health relevance
Narrative This cloud-based learning module will provide trainees with a comprehensive introduction to best practices in data exploration, analysis, and visualization. It emphasizes generating reproducible workflows and focuses on the statistical principles common to large ’omic data sets. Through this module, trainees will gain practical skills and knowledge necessary for handling complex datasets, enabling them to conduct more informed and effective pharmacological research.